GHES - NIAID - Villasis

PROGRAM SUMMARY
The objective of our LAUNCH program is to continue our global health research training program called the
Global Health Equity Scholars (GHES) designed to create a new community of researchers, educators, and
professionals who are prepared to address new and emerging global health challenges. We will build on the last
nine years of this training program to create a cadre of new researchers who will dedicate their research careers
to address the health problems that arise out of the inequity of human conditions prevalent in informal human
settlements (also referred to as slums). Rather than addressing one disease at a time, we propose to provide a
comprehensive, multidisciplinary, and integrated approach to deal with urban and rural informal human
settlement health issues, developed over many years by the participating faculty members of this program. This
program will comprise four US partner institutions (Consortium) - Yale University, Stanford University, University
of Arizona, and University of California at Berkeley, each led by a leader in global health research with more
than 10 years of collaboration among themselves. Together, core faculty mentors from these institutions conduct
research at 25 institutions in 21 countries, representing regions of Africa, Central and South America, the
Caribbean, Asia, the Pacific, and Eastern Europe. The GHES program will address a wide range of health
research topics including HIV/AIDs, emerging and high-consequence infectious diseases, non-communicable
diseases (NCDs), women's health, environmental health, mental health, interpersonal violence, substance
abuse, injuries, and the interaction of all of these health issues within the framework of slum health. Training will
target US postdoctoral fellows and pre-doctoral students and low and middle-income country (LMIC) postdoctoral
fellows. We plan to recruit 9-10 trainees/year with 60% of them as US postdoctoral fellows. The trainees will
spend 10-12-months at an LMIC site under the supervision of the Consortium and their collaborating LMIC
mentors. Workshops on global health research methods, skill development and career development will be
conducted both in-person and online. LMIC trainees will spend 2-3 months at US institutions to undergo training
in methods not provided at their institutions. All of the trainees will be provided with research and career
mentorship throughout their training and tracked for career development after completion of their GHES-
supported research work. Thus, under this program, we expect the trainees to be exposed to one important
theme in global health research - health equity - through research that deals with health concerns of vulnerable
populations residing in informal human settlements and provide them with an opportunity to become experts in
this new global health discipline. The overall impact of this training program is, therefore, to create a new cadre
of global health researchers and leaders who address the emerging health issues arising out of ever-expanding
informal human settlements of LMICs.

Public health relevance
PROGRAM NARRATIVE This training program is specifically designed to train a new cadre of researchers and leaders to address major but as yet under-studied public health problems engendered by conditions prevalent in urban and rural informal human settlements (slums) of low and middle-income countries (LMIC). This training is relevant also to developed countries as informal settlements in the form of homeless encampments expand. Selected candidates will undergo field training on site in LMICs to develop new global health research skills framed within our project research theme of health equity.